Addressing health disparities through a quantitative physiological database and precision systems modeling

PROJECT SUMMARY
In the realm of drug development and clinical evaluation, there is a pressing need to address the historical
exclusion of underrepresented populations such as children, women, racial minorities, elderly individuals, and
disease-specific groups. Regrettably, excluding these populations from drug testing results in unintended health
disparities, such as disproportionate occurrences of unforeseen adverse events and reduced efficacy of already
approved drugs. In the absence of diverse participation in clinical studies, a recent paradigm shift at the FDA
allows for new drug application submissions to utilize physiologically-based pharmacokinetic (PBPK) modeling
to describe the pharmacokinetic properties of a drug in specific populations. Although PBPK modeling is
promising, two fundamental challenges make these models less applicable to underrepresented populations.
First, the physiological data within current PBPK modeling tools have been derived from the reference population
(Caucasian/White). These inputs also include the levels of drug metabolizing enzymes, transporters, and
receptors (drug target proteins, DTPs). Second, the in vitro reagents used to model the drug-specific data are
not characterized in diverse human populations, thus limiting the accuracy of in vitro in vivo extrapolation (IVIVE)
predictors. In Phase I of our proposal, Precision Quantomics Inc. aims to fill these critical knowledge gaps
through development of the Underrepresented Population DTP (UpDTP) database of abundance of DTPs in
human liver and the creation of meticulously characterized population-specific in vitro reagents (PQ-ivR).
Together, these advancements will enable the generation of key data and reagents for PBPK models that will
more accurately predict drug pharmacokinetics and tissue drug concentration as surrogates of drug safety and
efficacy across diverse populations. The successful completion of Phase I will serve as a proof of concept, setting
a strong foundation for an expanded Phase II, where we will i) expand the UpDTP database to include other
tissues, populations, and animal models for PBPK modeling to pharmaceutical and biotech organizations ii)
develop custom reagents with precise scaling factors for pharmaceutical and biotech companies, and iii) validate
commercially available reagents with precise scaling factors for drug testing. In conclusion, our technology has
potential to advance drug development practices, elevate predictive accuracy, and ultimately contribute to
improved patient care across the currently underrepresented patient populations.

Public health relevance
PROJECT NARRATIVE The Underrepresented-Population-Drug-Target-Protein (UpDTP) database and population-specific in vitro reagents (PQ-ivR) developed and characterized by Precision Quantomics Inc. hold the potential to transform drug pharmacokinetics and safety testing for populations underrepresented in clinical trials. This endeavor presents a unique opportunity to mitigate unintended health disparities and improve drug development infrastructures, contributing to the advancement of public health.